Mechanisms of outflow tract morphogenesis regulated by extracellular matrix

PROJECT SUMMARY
Congenital heart disease (CHD) is the most common birth defect in humans and patients with conotruncal
defects comprise 30% of this population. Malformations of the distal aspect of the ventricle, the infundibulum,
and the proximal aspect of the great arteries lead to conotruncal anomalies. Specific examples include
transposition of the great vessels, double outlet right ventricle, and Tetralogy of Fallot. Among this patient cohort,
the mortality rate of 17% indicates a dire need for improvement in our understanding of the early developmental
signals guiding these aberrations in outflow tract (OFT) morphogenesis. The purpose of this application is to
uncover the molecular, cellular, and biomechanical mechanisms that account for disruptions in OFT development
and underlie human conotruncal CHDs. The emerging focus on extracellular matrix (ECM) in cardiac
development and disease points to this specialized, non-cellular protein network as a key player in sculpting the
conotruncus. Yet, we have limited appreciation of the individual ECM complements functioning during OFT
formation. We identified Fibulin (Fbln) proteins as novel regulators of the ECM essential for OFT growth and
expansion. Our preliminary data demonstrate that Fblns are required to establish the proper size of the OFT.
Fblns are required for accumulation of endothelial cells (ECs) through Smad3-dependent TGF-β cues. Further,
Fblns stimulate smooth muscle cell (SMC) differentiation and elastin assembly to establish the OFT caliber.
Importantly, tissue stiffness of this auxiliary chamber is elevated; this decreased elasticity contributes to altered
flow profiles. Altogether, our preliminary data highlight that the underlying mechanisms responsible for the
impaired OFT growth in the fbln loss-of-function model are multifactorial, representing a complex interplay of
defects in EC accumulation, SMC differentiation, tissue stiffness, and flow-related factors. We put forth the
overarching hypothesis that Fbln genes are essential to establish OFT dimensions and compliance by regulating
TGF-β signals in ECs and by promoting ECM deposition by SMCs, ultimately generating shear forces that
propagate further expansion. We will examine this model with the following aims: dissect the mechanisms
mediated by fbln2 in EC accumulation and OFT growth (Aim 1), investigate the function of Fbln5 in regulating
elastin assembly, stiffness, and OFT expansion (Aim 2), and determine shear stress and mechanobiological
mechanisms operating downstream of Fbln proteins via Piezo1 in ECs and SMCs (Aim 3). Insights gained from
these proposed studies will shed light on the biomechanical mechanisms responsible for compliance and elastic
deformation at the arterial pole with implications for diseases involving stenosis of the conotruncal region.
Furthermore, probing the cell type-specific functions of Fbln proteins will augment our ability to identify novel
therapeutic targets and protocols for tissue engineering of OFT conduits and artificial valves.

Public health relevance
PROJECT NARRATIVE Given the impressive mortality rate of pediatric patients with cardiac outflow tract (OFT) defects, there remains a critical need to improve medical and surgical strategies through precise delineation of the cellular, molecular, and biomechanical mechanisms responsible for OFT formation. Our studies illuminate Fibulin proteins, previously unappreciated ECM factors involved in OFT development, as critical regulators of TGF-β signaling and elastogenesis in the bulbous arteriosus. We anticipate that our innovative model characterizing the importance of ECM microenvironment in the evolution of OFT defects will fuel further identification of novel genes associated with congenital heart disease.